Dual E3 ligase function of TRIM25 in modulating innate immunity

Project summary/abstract
Innate immunity is crucial for human health and is primarily regulated by post-translational modifications, such
as ubiquitin and ubiquitin-like (ubl) modifiers. Specifically, Tripartite motif-containing protein 25 (TRIM25), is an
E3 ligase that enzymatically modifies substrates with ubiquitin and the ubl protein ISG15 and participates in
modulating innate immunity through the immunoreceptors Retinoic acid-inducible gene I-like receptors (RLRs).
Despite a general understanding of the role TRIM25 plays in the ubiquitination of RIG-I, little is known about the
role TRIM25 plays in ISGylation of RLRs and how TRIM25 selects between either process. Further, a new viral
mode of antagonism of TRIM25 by the Human Papilloma Virus have been discovered but have not been defined
at the molecular level. In this proposal, In the K99 phase of this award (Aim 1), I will investigate the mechanism
of the viral E6 antagonism of TRIM25 and how this inhibition effects the dual functions of TRIM25 to ubiquitinate
and ISGylate RLRs. In the R00 phase of this award (Aim 2, I will dissect the functional selectivity of TRIM25 and
the effects this has on substrate modification. This research will provide me with training in yeast display systems,
directed evolution and biochemistry and research on TRIM25 bifunctionality will be carried over to my own lab.
This award will enable me to take advantage of protein engineering and immunology expertise via my advisory
committee (Dr. Binning and Dr. Pilon-Thomas), as well as career development opportunities at the Moffitt Cancer
Center. I will also bolster my previous experience in diversity, equity and inclusion (DEI) advocacy with new
training to best position myself to further DEI efforts throughout my institution and community. I will attend
conferences and participate in Moffitt-sponsored and MOSAIC UE5 initiatives focused on lab management and
leadership. This will aid me transition to an independent scientist specializing in Ubiquitin biology and innate
immunity, which is a rapidly growing and important area of scientific research.

Public health relevance
Project Narrative In this K99/R00 proposal, I will investigate the antagonism and bifunctionality of the dual E3 ligase TRIM25, a modulator of the innate immune response pathway. I will leverage my training in protein engineering, biochemistry, and immunology to investigate how the HPV viral protein E6 antagonizes TRIM25 (K99) and to understand the dual function of TRIM25 as a Ub and ISG15 ligase (R00). By understanding the molecular mechanism that dictates TRIM25 bifunctionality, we will gain valuable insight into the complexity and regulation of innate immune signaling as well as the mechanisms of ISG15 recognition, transfer, and substrate targeting.